Academic Leadership Award at the Indiana University School of Medicine

Principal Investigator: Landreth, Gary E
Project Summary/Abstract
This academic leadership award application is directed at the development of coordinated and
comprehensive educational programs in aging, Alzheimer’s disease and related dementias at the Indiana
University School of Medicine (IUSM). A primary goal is to provide an organizational framework, anchored in
the Medical Neurosciences Training Program, to functionally integrate the activities of existing and developing
NIA supported resources at the IUSM. The NIA supports the Indiana Alzheimer’s Disease Research Center,
the National Cell Repository for Alzheimer’s Disease, the Regenstrief Institute and the Center for Aging
Research as well as the recently funded MODEL-AD center and LEADS clinical trial. Finally, Eli Lilly is
headquartered in Indianapolis and has a substantial research effort focused on Alzheimer’s disease. These
institutions comprise a unique and significant intellectual and infrastructural resource that will be leveraged in
the current proposal.
The IUSM and the NIA have recently committed substantial institutional resources to develop basic
science research efforts on AD and neurodegenerative diseases. However, the success of the investigative
effort will be contingent upon provision of a skilled workforce. The present application describes a plan to
employ the Medical Neuroscience Training program as a vehicle to enhance and coordinate the research and
training activities at the IUSM. The training program will simultaneously enhance and expand the institutional
research capacity by providing a talented pool of young investigators to faculty within the individual research
centers, and provide a high level training for these individuals. Importantly, the activities of the training
program provide a mechanism to promote interactions and collaborations between the faculty and research
staff at IUSM and Lilly who work on aging and neurodegenerative diseases.
The applicant, Dr. Gary Landreth, was recruited to IUSM to lead the development and restructuring of the
Medical Neurosciences Training Program. He brings to this effort 30 years of experience in Alzheimer’s
disease research and graduate education.
The Specific Aims of the application are:1) To restructure the Medical Neuroscience Training program
through a) modernizing the graduate curriculum to provide foundational training in the Neurosciences, aging
and neurodegenerative diseases, b) initiation of a postdoctoral training program to promote the professional
advancement of this important component of the scientific workforce and c) provide undergraduate research
experiences. 2) To employ the Medical Neuroscience Training Program as a vehicle to integrate the activities
of the various IUSM centers focused on Aging and Neurodegenerative diseases. 3) To promote translational
research interactions through the Medical Neuroscience Training Program with Eli Lilly.

Public health relevance
Project Narrative: The Indiana University School of Medicine is home to the Indiana Alzheimer’s Disease Research Center, the National Cell Repository for Alzheimer’s Disease, the Regenstrief Institute, the Center for Aging Research, the MODEL-AD Center, as well as administering the LEADS trial, which collectively receive >$100M in NIA funding. We propose to restructure the graduate program in Medical Neurosciences and initiate a postdoctoral training program to provide a skilled scientific workforce to these research centers. Importantly, we propose to employ the Medical Neurosciences Training Program to functionally integrate the scientific activities of the NIA supported investigators across IUSM and with Eli Lilly.